Cancer Prevention and Control Research Program

CANCER PREVENTION AND CONTROL RESEARCH PROGRAM
PROGRAM CODE: CPC

PROJECT SUMMARY/ABSTRACT
The mission of CPC is to prevent and control cancer by identifying factors that contribute to cancer
development and outcomes, and conducting interventions to address these factors. The Specific Aims of our
program are to: 1) identify lifestyle, environmental, and genetic risk factors in the etiology of cancer;; 2) assess
the patterns of care received by patients with cancer to identify effective strategies to improve patient
outcomes, and 3) conduct and evaluate lifestyle behavioral interventions for cancer prevention and control.
Dr. Melinda Irwin is Associate Director for Population Sciences and co-­leads the CPC program along with Dr.
Xiaomei Ma. Dr. Irwin’s expertise is in lifestyle behavioral interventions, so she oversees research related to
Aim 3. Dr. Ma’s expertise is in etiology and outcomes, so she oversees CPC research related to Aims 1 and 2.
Together, Drs. Irwin and Ma facilitate the collaboration of CPC members with members from other research
programs and disease-­aligned research teams (DARTs) with the goal of stimulating transdisciplinary research
that will impact cancer risk and mortality rates within and beyond the state of Connecticut.
Currently, there are 38 CPC members, with primary appointments in 11 departments and three schools. Our
cancer-­related funding (direct cost only) has increased 5% from $6.4M in the previous cycle to $6.7M in the
current cycle, of which $5.6M (84%) was peer reviewed and $2.5M was from NCI. Of the 793 cancer-­related
publications by CPC members from July 2012 to June 2017 (with 30% and 24% involving intra-­ and inter-­
collaborations), many have had a major impact on clinical and/or public health practice. Drs. Gross and Yu’s
(Radiobiology and Radiotherapy [RR] program) findings of early toxicity from proton beam therapy for prostate
cancer was cited in the decision by Blue Shield of California to stop reimbursing proton beam therapy for
prostate cancer. Dr. Niccolai’s HPV vaccination research has improved vaccination rates and has local, state,
and national impact. Drs. Irwin, Sanft, Cartmel, and Chagpar’s work, showing benefits of exercise and weight
loss on cancer biomarkers and treatment-­related side effects, is changing cancer care delivery with
implementation of lifestyle/behavior counseling in the clinic.
YCC and CPC leadership have developed a strategic plan to guide our future initiatives, with the primary goal
of adding depth and breadth to our existing strengths in cancer outcomes and lifestyle/behavioral research.
Goals within the next five years include recruitment of additional faculty in cancer outcomes and dissemination
and implementation research;; the submission of a P01 focused on randomized trials of energy balance in
cancer survivors;; two T32 applications on 1) obesity research and 2) cancer etiology, outcomes and
survivorship research;; and participating in submission of more SPORE applications with CPC members
leading projects.